ECHO Coordinating Center (CC) - Administrative Supplement

Project Summary:
To address knowledge gaps involving the impact of environmental exposures on health outcomes in children,
the Environmental influences on Child Health Outcomes (ECHO) program leverages extant and new pediatric
cohorts to test new hypotheses of how environmental exposures impact pediatric health. The Duke Clinical
Research Institute (DCRI) serves as the ECHO Coordinating Center (ECHO CC) to provide the organizational
framework for the management, direction, and overall coordination of all common ECHO activities.
To facilitate innovative, rigorous study protocols tailored to the scientific hypotheses; implement protocols
across a network of pediatric cohorts; and provide study support to ensure high quality study operations and
timely completion, the DCRI will use the proposed Administrative Supplement to conduct expanded scope of its
Oversight and Project Management Component.
The specific aims of the Administrative Supplement, led by Dr. Brian Smith, are to:
1) Support implementation of a standardized ECHO Cohort Protocol and monitor progress of individual Cohort
Study Sites.
2) Maintain central IRB functions, translate study- and site-level ECHO Cohort branded communications for
recruitment, enrollment, retention, and dissemination into Spanish, and maintain the ECHO Cycle 1
biorepository at Fisher Bioservices until transfer to the ECHO Laboratory Core at Vanderbilt University.
3) Support efforts to conduct an evaluation of intervention research conducted through the ECHO IDeA States
Pediatric Clinical Trials Network (ISPCTN).

Public health relevance
Project Narrative: Well-designed research is urgently needed to examine the impact of environmental exposures on health outcomes in children. The Duke Clinical Research Institute (DCRI) proposes to leverage its resources as the world’s largest academic research organization to continue its success serving as the Coordinating Center of the Environmental influences on Child Health Outcomes (ECHO) Program with a specific focus on monitoring progress of the study, maintaining study functions, and evaluating ECHO progress.